Histone mRNA Regulation in Development

Project Summary/Abstract
Metazoan replication-dependent histone mRNAs are the only eukaryotic mRNAs that lack a
polyA tail ending instead in a conserved stemloop. In contrast mRNAs for histone variants, e.g.
H3.3 and H2A.Z, are encoded by polyadenylated mRNAs. The genes for all five histone
proteins are clustered in metazoan genomes, and factors required for histone gene expression
are concentrated at the histone genes in a nuclear body, the histone locus body (HLB) which
contains three factors (FLASH, Mxc (NPAT) and U7 snRNP) that only function in histone mRNA
biosynthesis. Histone mRNAs are synthesized in the HLB. Our goal is to understand how the
HLB is assembled and concentrates the factors required for histone mRNA biosynthesis, and
activates expression only during S-phase. We have shown the core U7 snRNP is targeted to
the HLB in G1, but the active U7 snRNP is only assembled in the HLB in S-phase cells, when
the cleavage factor containing CPSF73, CPSF100 and symplekin is bound to U7 snRNP in the
HLB. The HLB forms immediately after mitosis and is inactive until cells enter S-phase.
Phosphorylation of Mxc (NPAT) by cyclin E/cdk2 activates histone gene expression. In this
proposal we address how U7 snRNP is targeted to the HLB (aim 1), how U7 snRNP is activated
inside the HLB (aim 2) and using the ability to remove specific factors from the nucleus during
early embryogenesis to determine the role of other factors in histone mRNA biosynthesis (aim
3).

Public health relevance
Narrative Our goal is to understand how the genes that code for the histone proteins, the proteins that package DNA, are regulated. Histones are synthesized only when DNA is replicated and their regulation is conserved in animals. The fruit fly, Drosophila, is the best genetic system to explore these mechanisms and since all animals use the same factors to regulate the proper amounts of histone, allows us to identify and understand how the human proteins function.